Genomic determinants of sleep traits as risk and protective factors for Alzheimer's disease

PROJECT SUMMARY
Alzheimer's disease (AD) is the most prevalent neurodegenerative disease in the United States and there are
no effective treatments or cure. The detection of modifiable protective or risk factors can improve the possibility
of intervention through life-style habits focused to reduce the disease risk or elevate disease protection. Sleep
disorders and disturbances have recently been recognized as risk factors for AD according to evidence from
epidemiological studies as well as associations with specific AD neuropathological hallmarks such as plaques
and tangles in the brain. However, the causal relationship between sleep disorders and disturbances and AD
has not been well established.
In this secondary data analysis proposal, we aim to study the causal effects of sleep traits on AD using
large publicly available genomics datasets including the UK Biobank (UKB), the AD Genetic Consortium
(ADGC), and others. We will use a bioinformatics workflow consisting of innovative analytical methods
designed to shed light on the causal relationship and identify specific genomics factors involved. The project
will be carried out as follows:
1) We will leverage large-scale genome-wide association studies (GWAS) conducted on sleep traits to
prioritize genes using a method (transcriptome-wide association study - TWAS) capable of detecting
phenotype-associated genes under genetic control and simultaneously related to changes in gene
expression. Then, AD RNA profiling studies will be analyzed using pseudotime algorithms, extracting latent
temporal information and ordering the samples according to disease progression. Genes identified in this
step (showing a high correlation with the disease progression and previously detected in the TWAS) will be
further investigated by Mendelian randomization to assess the causal relationship between sleep traits
(exposure) and AD (outcome).
2) A second independent analysis will be conducted by Mendelian randomization, prioritizing variants by
statistical significance from the large scale GWAS conducted on sleep traits and assessing the causal
relationship with AD. Additionally, a recently developed algorithm (latent causal variable method) will be
applied as well to detect causal relationships between sleep traits and AD.
This analytical workflow and the large size of the cohorts included will provide us with the statistical power to
identify modifiable risk and protective factors to demonstrate a causal relationship with AD.

Public health relevance
PROJECT NARRATIVE Several pieces of evidence suggest that sleep disorders are a risk factor for Alzheimer's disease. The identification of modifiable risk and protective factors improves the chance of lifestyle habit-based interventions aimed to reduce the onset of disease. We will investigate the causal relationship between sleep traits and Alzheimer's disease using large genomics data and state-of-the-art bioinformatics approaches.